Examining the impact of laboratory housing temperature on murine CD28 and the response to anti-PD-1

Project Abstract/Summary
For decades, animals in biomedical research have yielded significant scientific and medical breakthroughs by
generating the essential preclinical data that ultimately support the discovery and development of treatments
for human diseases, including cancer. However, while we to rely on animal models to investigate the
complexity of cancer and cancer therapies, these preclinical studies have alarmingly low success in
reproducibility, and even lower preclinical-to-clinical success rates. As per the Guide for the Care and Use of
Laboratory Animals 8th Edition, research institutions have standardized, minimum guidelines for the housing,
husbandry, and overall care for laboratory animals that they must adhere to. A mildly cool ambient
temperature is a critical aspect of animal housing that has been shown to elicit significant physiological
changes to research rodents, driven by the activation of the sympathetic nervous system and increased β-
adrenergic receptor (β-AR) signaling as a result of the systemic release of norepinephrine. This is due to the
compensatory response, known as non-shivering thermogenesis, employed by rodents housed at
temperatures that fall below their thermoneutral zone (which is the range of ambient temperatures at which
heat generated by basal metabolism is sufficient for maintaining homeostatic core temperature. ) Our lab has
previously established that standard (ST), subthermoneutral laboratory housing temperatures result in
significant impairment to the murine CD8+ T cell-dependent anti-tumor immune response compared to mice
house at thermoneutral temperatures (TT). Additionally, we have shown that the immune checkpoint inhibitor
αPD-1, an immunotherapy that has recently seen success as a front-line approach to treating cancers like
melanoma, has improved efficacy in treating tumor-bearing mice housed at TT in a β-AR-dependent manor.
Although published and preliminary data indicate a role for the co-receptor, CD28, in the diminished anti-tumor
function of CD8+ T cells as a result of increased β-AR signaling, a gap exists in our understanding of the
mechanisms underlying the reduced CD8+ T cell activation and effector function in mice housed at ST.
Therefore, we propose using genetically engineered mouse models to precisely interrogate CD28 signaling
and test hypothesis that standard housing temperatures impairs CD8+ T cell anti-tumor immunity and the in
vivo efficacy of αPD-1 via impaired CD28 co-stimulation. We will use in vitro and in vivo approaches to
examine the effects of housing temperature on CD8+ T cell CD28 expression and signaling, as well as tumor-
infiltrating lymphocytes in mice treated with αPD-1 therapy. The studies outline in this proposal have the
potential to identify a previously undefined mechanism by which subthermoneutral laboratory animal housing
temperatures influence experimental outcomes of cancer and immunotherapy models, while also
characterizing a widely underappreciated variable that exists in our animal models.

Public health relevance
Project Narrative The data generated in preclinical cancer research are often unreproducible and not translatable to the clinic. The goal of this proposal is to better understand the full impact of housing conditions on the animal models we rely on for studying cancer and the anti-tumor immune response by studying the influence of laboratory rodent housing temperature on murine CD8+ T cell anti-tumor immunity and response to immunotherapy. The knowledge gained from these studies will have direct implications on the role of laboratory housing conditions as a variable in murine models of cancer and immunotherapy.